Development and Testing of BAJJAJJA: An Intervention to Promote Economic Empowerment and Health of Grandmothers who Provide Primary Care for Grandchildren in Uganda

PROJECT SUMMARY/ABSTRACT
The proposed K01 award describes a research training program for Dr. Schola Matovu, an Assistant Professor
at the University of Utah College of Nursing. Her overarching goal is to become an independent investigator
conducting global health and gerontological research studies to improve the health and quality of life of older
adults with caregiving responsibilities, such as grandmother-caregivers (GMCs). This award provides support
for Dr. Matovu to achieve the following Career Development Goals to gain expertise in: 1) developing and
testing multi-component and culturally appropriate behavioral interventions in low-resourced settings; 2)
implementing aging and health disparities research related to aging, and performing geriatric health
assessment and coaching of community-dwelling GMCs; 3) behavioral clinical trial methodology; and 4)
research leadership and management skills. To achieve these goals, Dr. Matovu has assembled a dedicated
team of mentors and advisors with expertise in family caregiving research (Dr. Lee Ellington, US Primary
Mentor), design and implementation of psychosocial interventions for Ugandan populations impacted by
HIV/AIDS (Dr. Noeline Nakasujja, Uganda Primary Mentor), mixed research methods and behavioral
interventions (Dr. Melissa Watt), gerontological nursing, rural care, and nurse-led health coaching (Dr. Heather
Young), microfinance and social protection interventions (Dr. Fred Ssewamala), economics and women’s
empowerment (Dr. Eve Namisango), and biostatistics (Dr. Xiaoming Sheng).
There are an estimated 163 million children worldwide who are under the care of their grandparents or other
relatives. In Uganda, social determinants of health (i.e., poverty, wars, and maternal and perinatal conditions)
threaten the middle generation (age 15-49) and leave older adults, especially grandmothers (Bajjajja), to
become the safety net. Yet, in this region, knowledge about effective interventions that support the health and
wellbeing of these GMCs is limited to nonexistent. As such, Dr. Matovu proposes to refine, adapt, and test her
BAJJAJJA intervention. This will be achieved through three Specific Aims: 1) Refine and adapt the BAJJAJJA
intervention components through a collaborative and iterative feedback process with a diverse community
group of 18 members; 2) Test the feasibility, acceptability and preliminary efficacy of the BAJJAJJA
intervention in improving economic and health outcomes among 24 Ugandan GMCs; and 3) Explore the
barriers and facilitators to (3a) maintenance of the BAJJAJJA individual intervention benefits and (3b)
sustainability of the income generating activity at 6 months post-intervention. This innovative study will be the
first in Uganda (to our knowledge) to utilize a community-engaged approach that emphasizes the meaningful
involvement of community partners to develop an intervention that targets GMCs. Her outcomes will support
her future efficacy clinical trial to test a novel multi-component and community-engaged BAJJAJJA intervention
to promote the mental, physical, and economic wellbeing of GMCs.

Public health relevance
PROJECT NARRATIVE In the absence of child welfare and similar social services in the sub-Saharan setting, extended family members, often older grandmothers (Bajjajja), frequently step forward and bear the crucial burden of caring for children whose parents have died or are otherwise affected by poor social determinants of health. Considering the resulting public health crises many sub-Saharan Africa countries would face without the safety net afforded by grandmother-caregivers, it is critical to address health outcomes and wellbeing of these older adults, who are already vulnerable to age-related poor health outcomes and chronic socioeconomic stressors that may be further exacerbated by caregiving. This study will use mixed methods and a community-informed approach to refine, adapt, and test BAJJAJJA (Building A Joint Action for JaJJAs), an innovative, multi-component intervention constituting of an income generating activity (IGA, facilitated by IGA experts) and health coaching (facilitated by visiting nurses).